Core Vision Grant - Administrative Core

Abstract
The Director of the Vision Core will be Anthony Movshon, assisted by an Executive Committee consisting of
the four module directors and/or their four associate directors, and two outside advisors, David Williams of the
University of Rochester and Dennis Levi of the University of California at Berkeley. The Director and the
Executive Committee will oversee the operation and allocation of Core resources.